Nebraska Research Network in Functional Genomics

Overall Component
Project Summary
The mission of the Nebraska IDeA Networks of Biomedical Research Excellence (NE-INBRE) is to stimulate and
develop biomedical research capacity at institutions of higher education in Nebraska. The NE-INBRE is
structured around two major components: primarily undergraduate institutions (PUIs) and PhD granting research
institutions (RIs). Support for each PUI consists of: 1) campus research capacity development through support
for faculty research and infrastructure enhancement, and 2) development of the undergraduate research pipeline
of students through the NE-INBRE Scholars program. Expanding research capacity at the RIs includes providing
significant support to multiuser core facilities in order to allow investigators from PUIs and RIs access to cutting-
edge technology. The nine participating PUIs in the NE-INBRE research network include two publically supported
State Colleges, three campuses of the University of Nebraska system, and four private institutions. The three
participating RIs in the research network include two campuses of the University of Nebraska system and one
privately supported medical center (Creighton University). Cutting-edge multiuser core facilities include cores in
genomics, data science, and advanced microscopy. The three themes reflect the scientific foci of the NE-INBRE,
infectious diseases, cancer biology, and cell signalling. These themes serve to link faculty and students at the
separate institutions into productive networks based on their areas of expertise and interest. Throughout the
tenure of the NE-INBRE, its primary objective at the undergraduate level has been to provide and expand
research opportunities for students and create a pipeline of students to enter into biomedical research and other
health professions. NE-INBRE investments in faculty research projects and infrastructure at the PUIs have
created opportunities for both NE-INBRE Scholars and other undergraduate students to become involved in
advanced biomedical research.

Public health relevance
Overall Component Project Narrative The NE-INBRE is designed to increase the biomedical research and training capacity at institutions of higher education and contribute to the development of the scientific workforce in the state. Primarily undergraduate institutions receive funding to enhance their faculty research and establish modern laboratories, thus providing opportunities for undergraduate students to engage in modern research and consider entering a career in research and/or the health professions. Research institutions receive funding to support the development of multiuser core facilities that make cutting edge technology available to research programs on these campuses.